Developmental Funds

The Cancer Therapy & Research Center (CTRC) at the University of Texas Health Science Center at San Antonio requests $ 200,000 per year in developmental funds, 9.7% of the overall direct Cancer Center Support Grant (CCSG) request that will be used for: Pilot research funding to CTRC members each year. Funds($150,000/year) will be awarded following competitive RFAs. Additional pilots will be funded using CTRC funds. Funding ($50,000 per year), for start-up packages for high priority new faculty recruitment The remainder of these start-up packages will be leveraged with CTRC and institutional funds.

Public health relevance
The CTRC requests Developmental Funds from the Cancer Center Support Grant to fund pilot research projects and assist in the recruitment of new faculty. Both will support the overall the CTRC's mission to reduce the cancer burden in Texas.